Occupational exposure and the developmental-basis of AD

Abstract The effects of lead (Pb) on the developing nervous system are well documented and the removal of Pb from gasoline has greatly diminished the risk from environmental exposure to Pb. However, exposure to Pb remains a serious occupational concern. Many workers who are currently employed in industries such as mining, construction, and manufacturing are faced with this occupational hazard everyday. While adult exposure to Pb can damage various organs in the body, new data suggests that prior exposure to Pb may intensify these responses. These data arise primarily from epidemiological observations that have shown that some adult chronic non-communicable diseases are not only influenced by genetic and life-style factors but by environmental factors acting in the perinatal and infant phases of life. Recently, Basha et al., (2005) reported that developmental exposure of rats to the heavy metal Pb resulted in a delayed over-expression (20 months later) of the Amyloid Precursor Protein (APP) and its amyloidogenic Ab product. APP and Ab are integral components of amyloid plaques, the key pathological feature of Alzheimer[unreadable]s disease (AD). Additionally, developmental exposure to Pb resulted in an accumulation of oxidative DNA damage in old age, a process associated with many adult diseases (Bolin et al., 2006). These delayed effects indicate that a critical developmental window exists for chemical exposure that predetermines future susceptibility to disease and suggests that workers with a past history of exposure may be at greater risk of developing certain diseases. To address this issue, we will use animal models to examine the consequences to biomarkers of neurodegenerative diseases in the brains and blood of animals who were developmentally-exposed to Pb and which undergo repeated exposure as adults. We further would like to examine the mechanisms associated with sensitization of animals to disease by early life exposure and how such processes respond in the event of re-exposure during adulthood.